Structure and Function of the Acetylcholine Receptor

ABSTRACT- Members of the nicotinic acetylcholine receptor (AChR) gene family mediate synaptic
transmission throughout the central and peripheral nervous systems. The AChR family is part of the
superfamily of pentameric ligand-gated ion channels (pLGICs) that also includes receptors activated by the
neurotransmitters serotonin, gamma-amino-butyric acid, and glycine. Collectively, the pLGIC superfamily
mediates the majority of neurotransmission occurring on the millisecond time frame. The over-arching goal of
our research is to understand mechanisms by which AChRs transduce a chemical stimulus into an electrical
response, a process central to understanding disorders of excitability caused by inherited mutations of AChR,
and to developing drugs to treat such disorders. Toward this end, the proposed studies address key gaps in
our understanding of chemo-electrical transduction by the AChR spanning from basic to translational science.
The first aim is to delineate biophysical and structural mechanisms by which ion transport through the AChR
channel is coupled to gating of the channel between inactive and active states. The second aim is to elucidate
biophysical and structural mechanisms by which changes in extracellular calcium, a major regulatory ion,
modulate the strength of signaling by the major type of AChR in the brain. The third aim is to delineate
mechanisms by which inherited mutations in the major type of brain AChR cause epilepsy, and develop
mechanism-based therapeutic solutions. To achieve these aims, we employ a multidisciplinary approach that
includes functional measurements from single AChR molecules, computational methods to simulate atomic
scale interactions between AChRs and physiological modulators, and atomic-scale structure determination of
normal and diseased AChRs. The overall studies will resolve key gaps in understanding AChR signaling
mechanisms central to physiology, pharmacology, and pathophysiology. The insights will apply not only to
AChRs from muscle and brain studied herein, but also to other members of the pLGIC superfamily.

Public health relevance
PROJECT NARRATIVE- Nicotinic acetylcholine receptors (AChRs) mediate moment-to-moment chemical signaling throughout the central and peripheral nervous systems, and are targets for a broad spectrum of neurological diseases and therapeutic drugs. The proposed research will determine biophysical and structural mechanisms behind signaling, modulation of signaling and disorders of signaling mediated by AChRs. The insights from this research will enable improved diagnosis and treatment of neurological diseases and development of therapeutic drugs.